Administative Supplement: Immunologic and Neurodevelopmental Consequences of Neonatal Anemia and Thrombocytopenia and their Treatments

Abstract This attachment is not required for a Diversity Supplement application. Please refer to the attachments uploaded to the “Other Attachments” section of this form as directed by NHLBI's Research Supplement Application Guidelines

Public health relevance
Narrative This attachment is not required for a Diversity Supplement application. Please refer to the attachments uploaded to the “Other Attachments” section of this form as directed by NHLBI's Research Supplement Application Guidelines